ANTI FUNGAL DRUG DESIGN CANDIDA ALBICANS DUTPASE

Fungal infections are becoming an increasing public health concern, particularly among immune compromised patients or those undergoing chemo- and/or radiotherapy. Two fungi of particular concern are Aspergillus niger and Candida albicans. We have obtained crystals of the essential DNA repair enzyme dUTP pyrophosphatase (dUTPase) from C. albicans. Determination of the structure of the fungal dUTPase, and comparison with the structure of the human enzyme, recently determined in our laboratory, may allow design of inhibitors specific for the C. albicans enzyme for use as anti-fungal agents.